2015 Dendrites: Molecules, Structure and Function Gordon Research Conference and Seminar

? DESCRIPTION (provided by applicant): Dendrites integrate thousands of synaptic inputs and regulate output from neurons. As a result of amazing advances in molecular genetic, imaging and electrophysiological recording methods, neuroscientists are now able to probe dendritic signaling in identified neurons, circuits and intact animals. The GRC 2015 Dendrites conference will promote discussion of new research on the structure and function of dendrites. The pace of discovery in dendrite research has never been faster, given the numbers of outstanding neuroscientists, engineers and theorists who devote their energies to this topic. This conference will strengthen communication between scientists working on dendrites and ensure that the rapid pace of discovery continues.

Public health relevance
PUBLIC HEALTH RELEVANCE: Dendrites are the sites of the majority of synaptic input and information processing in most neurons. This Gordon Research Conference and Symposium will convene investigators of all levels from the diverse fields of neuroscience to present and discuss their research on dendrite structure and function in health and disease. This conference will strengthen communication between scientists working on dendrites and ensure that the current rapid pace of discovery continues.